Core A: Administrative Core

SUMMARY Core A
An Administrative Core will coordinate and facilitate all activities within the U54 SenNet Murine Tissue Mapping
Center (mTMC) Research Group. Core A will be headed by Drs. Dixit and Montgomery, who are NIH funded
investigators and bring many years of experience at managing large collaborative research projects. This Core
will be responsible for the overall organization, management, decision-making, and communication in the project,
as well as utilization of institutional resources. The Administrative Core will provide oversight and consultation
to each of the Cores to ensure that scientific objectives are met and that there is optimal utilization of resources.
Specifically, the Administrative Core will: 1) monitor and assist each group so that their goals are achieved, and
emergent problems are expeditiously addressed; 2) provide fiscal management and ensure cost-effective
utilization of U54 resources; 3) ensure timely sharing of SOPs and data packages; 4) support collaborative
activities and pilot studies; 5) promote the communication and dissemination of research and technology; and 6)
organize the presentation and publication of data. This Core will also ensure data sharing, protection of
intellectual property, and long-term data storage in coordination with the SenNet CODCC. Core A will have
scientific input from both an Internal and External Advisory Committee and full partnership across the SenNet to
advance development of the atlas. The Core Directors chair progress meetings and advisory committees to
oversee progress and promote the success of the mTMC.